Validating Terra, a device for closed-loop hot-flash cooling relief and sleep improvement

PROJECT SUMMARY
Vasomotor symptoms (VMS), including nighttime hot flashes, significantly impact the well-being of 80% of
menopausal women, leading to sleep disturbances, reduced quality of life, and an elevated risk of developing
chronic diseases such as diabetes, depression, and cardiovascular disorders. While hormone replacement
therapy (HRT) offers a common solution, its associated health risks prompt the search for safer, more effective
treatments. Traditional remedies and cooling products provide partial relief but lack the ability to dynamically
respond to VMS, often failing to prevent sleep disruption effectively.
Amira introduces Terra, a pioneering sleep technology designed to address these challenges through an
innovative closed-loop temperature control system. Terra distinguishes itself by utilizing smart wearable
sensors to detect the onset of hot flashes in real-time and employing targeted cold bursts instead of continuous
cooling, offering a personalized and more comfortable cooling experience throughout the night. This approach
not only aims to mitigate hot flashes but also optimizes overall sleep temperature, adapting to the user’s
changing needs across different sleep stages.
The Terra platform leverages a combination of biofeedback, advanced electrode technology, and machine
learning algorithms to accurately predict and respond to VMS, ensuring rapid cooling in less than 5 seconds
and significantly improving sleep quality by minimizing awakenings. Preliminary tests of proof-of-concept
versions have validated the system's potential, demonstrating its capability to detect and preemptively counter
hot flashes, thereby enhancing sleep quality.
In the proposed Phase I SBIR study, Amira seeks to further evaluate Terra’s effectiveness through a
comprehensive in-home study focusing on the accuracy of its biometric detection system and the efficacy of its
closed-loop temperature control in managing VMS. This research will contribute to the development of a
non-pharmacological, user-friendly solution for menopausal women, aligning with the mission to improve health
outcomes by providing innovative responses to unmet medical needs.

Public health relevance
PROJECT NARRATIVE Amira’s proposed research aims to enhance public health by developing Terra, a smart wearable sensor and hydronic cooling pad system designed to mitigate menopausal vasomotor symptoms (VMS) and improve sleep quality. By offering a non-hormonal, personalized treatment option, this project addresses the widespread issue of nighttime hot flashes, reducing the risk of associated chronic conditions such as diabetes, depression, and heart disease in menopausal women.